Improving multimodal physical function in adults with heterogeneous chronic pain; Multi-site feasibility RCT (Diversity Supplement)

PROJECT SUMMARY/ABSTRACT:
Spanish-speaking Hispanics/Latinos are the largest and fastest ethnic/racial minority group in the United States
(19%). This group experiences significant disparities in pain treatment and outcomes relative to their English-
speaking and White counterparts. Cultural and linguistic adaption of pain interventions can help minimize these
disparities. Informed by Barrera’s Heuristic Framework for Cultural Adaptations of Clinical Interventions1 and the
National Center for Complementary and Integrative Health (NCCIH) Model for developing and testing mind-body
interventions,2 Dr. Giraldo-Santiago will culturally and linguistically adapt a mind-body and walking program
(GetActive-Fitbit tested in parent R01 5R01AT012069-02; PIs Vranceanu and Greenberg) to the unique needs
of Hispanic/Latino adults with chronic pain. Dr. Giraldo-Santiago will conduct this work in MGH Revere Health
Center, an underserved community clinic with a high representation of Hispanic/Latino adults. This diversity
supplement (PA-23-189) will serve 3 main purposes. First, it will increase the reach of the parent grant, which to
date has had very limited participation of Hispanic/Latinos (~2%) due to lack of cultural and linguistic program
adaptation. Second, it will allow us to include Spanish-speaking Latino individuals in our next grant (UG3/UH3),
a fully powered multi-site efficacy clinical trial of the GetActive-Fitbit program. Third, this diversity supplement
will support the career of Dr. Natalia Giraldo-Santiago, a native Spanish-speaking Puerto Rican social work
researcher in training within the Center for Health Outcomes and Interdisciplinary Research at MGH. This
diversity supplement will allow Dr. Giraldo-Santiago to gain expertise in 1) qualitative methods, 2) the application
of cultural adaptation frameworks to mind-body interventions for Hispanic/Latino adults with chronic pain, and 3)
grantsmanship and research dissemination skills under the mentorship of the parent grant MPIs Dr. Greenberg
(primary mentor) with the support of Dr. Vranceanu (co-mentor). At the end of the supplement year, Dr. Giraldo-
Santiago will be ready to submit a K23 to transition to independence.

Public health relevance
PROJECT NARRATIVE: Spanish-speaking Hispanics/Latinos adults experience significant disparities in pain treatment and outcomes relative to their English-speaking White counterparts. This diversity supplement will adapt the study design and materials of the parent grant to reflect the cultural needs and preferences of Spanish- speaking Hispanic/Latino adults with chronic pain. This will provide Dr. Giraldo-Santiago with the necessary training to advance her career development goals in qualitative methods and cultural adaptation of mind-body interventions.